UTAH CENTER FOR HUMAN GENOME RESEARCH

The Utah Center for Human Genome Research builds on existing strengths to cultivate a comprehensive approach, addressing crucial technology development problems ranging from fast DNA sequencing methods to the location of genetic markers on human chromosomes. The basic DNA sequencing technologies become the core technology for two distinct applications: capture of continuous DNA sequence from a series of target genome regions and development and mapping of genetic linkage markers, used to precisely map human genes involved in disease. To create the special blend of molecular biology and engineering that is essential for this goal oriented project, talents from many parts of the U. of Utah have been drawn into an interactive group. Substantial emphasis on development and implementation of informatics systems reflects our experience and judgment of the importance of this component in large scale data acquisition enterprises. In each area pilot application projects will test the scaling properties of the technologies. We identify a further important goal of providing access to the new technologies, initially specifying a laboratory to provide access to linkage technology.